New Mexico Pregnancy Risk Assessment Monitoring System

Project Summary/Abstract New Mexico Pregnancy Risk Assessment Monitoring System, Category A. Core surveillance DP-16-001 CDFA 93.946 NM PRAMS has been part of the CDC PRAMS cooperative agreement since 1996. The project has achieved great success in operational and data-to-action translation for the entire project period. As a minority-majority state, NM PRAMS preceded many PRAMS states in challenges with survey response. The marked decline in survey response around year 2006 data collection turned around significantly from 2011-2014 when response rates exceeded the 65% target. The rigor with which PRAMS staff apply efforts to maintain this survey response is remarkable and speaks to the solid level or partnership and collaborations across the state. NM is among only three PRAMS states (NM, TX, HI) with more than a 50% minority birth population. This makes the data particularly important and the collection of those data very challenging among all strata. NM PRAMS overcame significant barriers in representation by making the survey more accessible (hand delivery on tribal reservations), increasing project visibility, and by solidifying fiscal agreements with key client/data partners (Medicaid, Title V and private foundations) to match federal funds. NM PRAMS enjoys an active and highly committed Steering Committee and has an impressive policy development track record resulting from PRAMS data application throughout the state. The staff members are consistent and highly suited to the work of public health surveillance. NM PRAMS is a key contributor to the Title V and NMDOH Department of Health Strategic plans. The surveillance responds to and clearly guides priorities for Maternal and Child Health in the state of New Mexico. New Mexico has a rich cultural heritage reflected in American Indian, Hispanic and non-Hispanic ‘Anglo’ settlements. These communities are joined by flourishing African-American, Asian and Pacific Islander families as our population grows. The PRAMS project addresses the complexity and realities associated with a diverse population living in poverty but excelling in its concern for the health of mothers and infants. The PRAMS cooperative agreement provides a context for understanding health risks, barriers to access, and protective factors only gleaned through the lens of ongoing rigorous research. Through the aims and objectives stated in the Research Plan, it is clear that PRAMS is not only a mainstay for Public Health in NM, but truly reflects the personal fabric of the women answering the survey and sharing their experiences to help future generations of NM mother and infants.

Public health relevance
Project Summary/Abstract New Mexico Pregnancy Risk Assessment Monitoring System, Category A. Core surveillance DP-16-001 CDFA 93.946 NM PRAMS has been part of the CDC PRAMS cooperative agreement since 1996. The project has achieved great success in operational and data-to-action translation for the entire project period. As a minority-majority state, NM PRAMS preceded many PRAMS states in challenges with survey response. The marked decline in survey response around year 2006 data collection turned around significantly from 2011-2014 when response rates exceeded the 65% target. The rigor with which PRAMS staff apply efforts to maintain this survey response is remarkable and speaks to the solid level or partnership and collaborations across the state. NM is among only three PRAMS states (NM, TX, HI) with more than a 50% minority birth population. This makes the data particularly important and the collection of those data very challenging among all strata. NM PRAMS overcame significant barriers in representation by making the survey more accessible (hand delivery on tribal reservations), increasing project visibility, and by solidifying fiscal agreements with key client/data partners (Medicaid, Title V and private foundations) to match federal funds. NM PRAMS enjoys an active and highly committed Steering Committee and has an impressive policy development track record resulting from PRAMS data application throughout the state. The staff members are consistent and highly suited to the work of public health surveillance. NM PRAMS is a key contributor to the Title V and NMDOH Department of Health Strategic plans. The surveillance responds to and clearly guides priorities for Maternal and Child Health in the state of New Mexico. New Mexico has a rich cultural heritage reflected in American Indian, Hispanic and non-Hispanic ‘Anglo’ settlements. These communities are joined by flourishing African-American, Asian and Pacific Islander families as our population grows. The PRAMS project addresses the complexity and realities associated with a diverse population living in poverty but excelling in its concern for the health of mothers and infants. The PRAMS cooperative agreement provides a context for understanding health risks, barriers to access, and protective factors only gleaned through the lens of ongoing rigorous research. Through the aims and objectives stated in the Research Plan, it is clear that PRAMS is not only a mainstay for Public Health in NM, but truly reflects the personal fabric of the women answering the survey and sharing their experiences to help future generations of NM mother and infants.